Endothelial-Leukocyte Adhesion in CAR T Cell Treatment Associated Neurotoxicity

PROJECT SUMMARY
This project studies the mechanism of neurologic toxicity in chimeric antigen receptor (CAR) T cell
therapy. CAR T cells are genetically modified, patient derived T cells that use the CAR to recognize and destroy
malignant target cells. Although CAR T therapy has shown impressive results against leukemia and lymphoma,
approximately 30-40% of patients experience neurologic side effects in the first month after receiving CD19-
targeted CAR T cells. This includes cognitive disturbances, seizures, and in rare cases fatal cerebral edema.
Systemic cytokine release syndrome after CAR T cell infusion is a well-established risk factor for neurotoxicity,
but the connection between systemic inflammation and brain dysfunction is poorly understood.
To study the mechanisms of neurotoxicity, we have developed an immunocompetent mouse model. After
treatment with high dose CD19-directed murine CAR T cells, mice develop motor and balance difficulties, as
well as brain microhemorrhages. Surprisingly, we found that >10% of cortical capillaries are obstructed by white
blood cells during neurotoxicity. This was accompanied by capillary remodeling and decreased vessel coverage
by pericytes. Based on these findings, we now propose the following experiments:
Aim 1: What molecular mechanisms cause white blood cells to plug capillaries during neurotoxicity? We
will use in vivo two-photon imaging in mice to determine which cell types cause the capillary plugging – the
mouse’s own or the transferred CAR T cells? We will then measure how CAR T cell treatment changes the
expression of adhesion molecules in brain capillary endothelial cells and in leukocytes, and test whether
blockade of these adhesion interactions can prevent capillary plugging and neurotoxicity.
Aim 2: Is neuroendothelial-leukocyte adhesion increase in human microvessels during neurotoxicity? In
parallel to our work in mice, we will use a 3D in vitro model of human brain capillaries to measure how soluble
factors in patient plasma affect adhesion molecule expression in the endothelium. We will then test whether
white blood cells from CAR T cell patients with neurotoxicity have increased predilection for plugging synthetic
microvessels that mimic capillaries, and whether we can prevent this plugging by blocking adhesion molecules.
Aim 3: Can the strength of cell-cell adhesion signaling separate CAR T cell efficacy from toxicity? We will
use quantitative multiplex immunoprecipitation to probe protein-protein interaction networks in CAR T cells that
cause high or low neurotoxicity in mice to understand what activation states are conducive to neurotoxicity. We
will then test whether knock down of adhesion molecule expression can direct CAR T cells away from a toxicity
phenotype by impairing their ability to signal to other cells, and to adhere to the brain microvasculature.
This work is innovative because it combines advanced imaging, in vitro modeling techniques, and protein
network analysis in a unique collaboration between neuroscience, vascular biology, and oncology. The work is
significant because it addresses key safety issues in emerging cancer immunotherapy modalities.

Public health relevance
PROJECT NARRATIVE This project investigates the mechanism of neurologic toxicity in chimeric antigen receptor (CAR) T cell therapy, a novel and highly effective cancer immunotherapy that unfortunately has frequent side effects of cognitive disturbances, seizures, or even fatal brain swelling. We have found in a mouse model that white blood cells obstruct capillaries in the brain during neurotoxicity. We will now determine whether dislodging these cells from the vessels can prevent neurotoxicity, whether this mechanism can be recapitulated in a human in vitro brain microvessel model, and how the signaling properties of CAR T cells contribute to toxicity and cell-cell adhesion.